Neuroanatomy/Histology/Brain Injection Core

ABSTRACT
The Neuroanatomy/Histology/Brain Injection Core (Core C) will facilitate neuroanatomical and histological
studies for PPG Members. It will be used regularly by investigators from all 3 projects described in the PPG. Dr.
Laurent Gautron will coordinate these services and resources, and will provide periodic training of personnel
on the use of the equipment. Core C will also be an essential component of the characterization and validation
of gene specific deletion mouse models proposed by all 3 projects. Core C is equipped with the equipment and
expertise to provide the following services:
Core C will provide the following services:
 Routine histology
 Immunolabeling
 RNA in situ hybridization
 Stereotaxic surgeriesMicroscopy
 Brain microdissection
 RNA isolation and qPCR analysis.
The technical expertise in Cores C will provide multiple benefits to project investigators:
 Centralized Core services are more cost effective and prevent the duplication of reagents across
Program investigators.
 Uniform standards and protocols will ensure that results from all Projects can directly be compared
 Provides technical expertise for protocols that are not routinely performed by Program investigators

Public health relevance
NARRATIVE The Neuroanatomy/Histology/Brain Injection Core (Core C) serves a central role with respect to facilitating surgical and histological experiments. Core C will also be an essential for validating and characterizing the gene-specific mouse models in this propsal. Centralized Core services provide procedural consistency, are more cost effective, and make technically challenging assays available to all investigators.